CELLULAR MECHANISMS OF POSTHYPOXIC CARDIAC DYSFUNCTION

Our preliminary studies show that reoxygenation of single cardiac myocytes after brief or prolonged hypoxia causes functional abnormalities analogous to those seen in reperfused myocardium: prolonged relaxation, manifestations of calcium overload and, after long hypoxic periods, cell destruction. To study the mechanism of these changes, single myocytes, under direct observation, will be made hypoxic (PO2<0.02 torr) using the Laminar counterflow Barrier Well technique developed by the Sponsor and the Candidate. Changes in intracellular calcium will be measured using the fluorescent probe indo-1, intracellular pH using the new probe SNARF-1, and intracellular sodium using the new fluorescent crown ether SBFI. Mechanical shortening and membrane potential/currents will be measured simultaneously. By manipulating extracellular pH and sodium, intracellular pH (by varying PCO2) and phosphate (by pipette dialysis) we will test the hypothesis that post-hypoxic delayed relaxation is due to altered myofilament function, determine whether it can be accounted for by changes in intracellular pH and Pi, and test the hypothesis that sodium-calcium exchange, possibly linked to sodium-hydrogen exchange, is critical in the calcium-mediated destruction of cells reoxygenated after prolonged hypoxia.